MRI assessment of cerebral oxygen extraction fraction (OEF) in the medial temporal lobe as a biomarker in Alzheimer's disease

Project summary/Abstract
Alzheimer's disease (AD) is the most common type of dementia, affecting ~5.7 million people in the U.S.
alone. Early and accurate diagnosis of AD are critically important in its management. MRI has been playing an
important role in the diagnosis of AD. However, currently the primary MRI-based biomarker has been structural
MRI measures, specifically atrophy in medial temporal lobe (MTL), which is a crucial region for memory
formation. Unfortunately, structural atrophy represents a late stage of MTL impairment and is generally
considered irreversible. Therefore, it is highly desirable to develop a biomarker based on the function, rather
than structure, of MTL, which may provide an early-diagnosis tool in AD. Cerebral oxygen extraction fraction
(OEF) is an important index of the brain's energy metabolism. Because neural activity is tightly coupled to the
brain's energy consumption, measurement of OEF in the medial temporal lobe (MTL-OEF) is thought to
provide an assessment of brain function in this critical region and may serve as a novel biomarker in AD. In
fact, previous studies have demonstrated that OEF, even only measured at a global level, is sensitive to AD.
Since MTL is an early site of pathological involvement in AD, localized MTL-OEF is expected to have superior
sensitivity and specificity compared to previous global OEF measurements. However, quantitative
measurement of MTL-OEF remains a challenge in the MRI field, due to technical issues such as macroscopic
susceptibility artifacts and partial volume effects. Therefore, the goals of the present exploratory/developmental
(R21) study are to develop a novel non-invasive MRI technique to measure MTL-OEF and then apply it to the
study of mild cognitive impairment (MCI), which is an early form of AD. This study has two specific aims. Aim 1
is the technical development. We will develop a novel MRI pulse sequence and related scan procedures to
specifically measure the blood oxygenation in veins draining the MTL tissue (i.e., the basal veins of Rosenthal),
so that MTL-OEF can calculated as the arterio-venous difference in oxygenation. This Aim will also compare
this new technique to a 15O-PET-validated TRUST MRI technique and will determine benchmarks of the
technique such as the accuracy of OEF quantification, test-retest reproducibility and the sensitivity to known
alterations in OEF via physiological challenges. Aim 2 is to evaluate the initial clinical utility of MTL-OEF as a
functional biomarker in MCI patients. This study focuses on MCI rather than full-blown AD because it is an
early form of the disease and most treatment trials are aimed at this stage. MTL-OEF will be compared
between MCI patients and cognitively normal elderly controls. Associations of MTL-OEF with blood plasma AD
biomarkers (including beta-amyloid and phosphorylated tau) and cognitive function (especially episodic
memory) will be examined. MTL-OEF will be compared with MTL volume (measured by MRI volumetry) in
terms of the sensitivity to cognitive decline at this early stage of AD.

Public health relevance
Early and accurate diagnosis of Alzheimer's disease (AD) requires non-invasive biomarkers to assess the brain's function. This project will develop a novel non-invasive MRI technique to measure the cerebral oxygen extraction fraction in the medial temporal lobe, and evaluate its clinical utility as a functional biomarker in patients with mild cognitive impairment, which is an early form of AD.